Anxious Solitary Youth Come of Age: Interpersonal Processes Link Youth Trajectories to Adjustment in Young Adulthood

PROJECT SUMMARY/ABSTRACT
Youth with anxious solitude (AS), the most common form of social withdrawal, remain alone in familiar social
contexts (school) more often than peers due to social anxiety. Youth AS forecasts profound impacts on adult
mental health (anxiety, depression) and delays in adult developmental milestones for participation in family and
society (participation in higher education/work; achieving a career, income, romantic partnership, procreation).
We will investigate these patterns in a young adult follow-up study of the 230 participants from the NIH-
supported longitudinal study Multiple Trajectories in Anxious Solitary Youth. This sample was drawn from US
public schools and will be age 23-26 at the time of the proposed study. This sample is unique because 1) half
of participants were originally selected for AS and the other half were demographically-matched comparison
children, 2) AS was assessed with school-based peer reports. Our investigation will connect 5 yrs of existing
data on psychosocial development in 3rd-7th grade to new multi-informant data in young adulthood (age 23–26).
Aim 1: Test youth AS trajectories (3rd-5th grade) as predictors of young adult adjustment (1 wave: 23-26).
We hypothesize youth high and increasing AS trajectories will predict young adult maladjustment, including
poor quality relationships, affective-behavioral continuity, social anxiety, delayed developmental milestones.
Aim 2: Test gender differences in the likelihood that youth AS trajectories predict young adult
adjustment. We hypothesize that youth high and increasing AS trajectories will predict pervasive detriments to
young adult adjustment (specified in Aim 1) for both sexes (no gender moderation), in contrast to previous
research downplaying detriments to women's societal participation. However, marriage and procreation delays
may occur only in men with youth high-increasing AS trajectories.
Aim 3: Test interpersonal processes as links between youth AS trajectories and young adult
adjustment. We hypothesize that youth peer exclusion will link (mediate) youth high and increasing AS
trajectories and young adult maladjustment because it limits opportunity for interpersonal learning processes
critical to healthy development. We will also test as mediators additional forms of youth and young adult
interpersonal adversity (relationship quality), related interpersonal learning and self-development processes.
Results promise to 1) update knowledge of adjustment in American young adults with youth histories of AS; 2)
facilitate recognition of developmental challenges in young women with youth AS, counteracting the tendency
to downplay impacts on women's societal participation; and 3) generate new knowledge of interpersonal
processes that link youth AS to adult adjustment. Knowledge of interpersonal processes promises to inform
prevention efforts and enable families, educational institutions, and workplaces to foster the inclusion, health,
and development of their vulnerable members. This research will provide preliminary data for a future R01.

Public health relevance
PROJECT NARRATIVE This research investigates young adult outcomes of childhood and early adolescent anxious solitude (social withdrawal) pathways, including young adult mental health and delayed attainment of adult developmental milestones for participation in families and society (e.g., education, career, committed romantic partnerships, procreation). Moreover, this research seeks to model how interpersonal interaction and relationship processes link youth anxious solitude to subsequent young adult outcomes. Knowledge of these interpersonal processes promises to inform prevention efforts and enable American families, educational institutions, and workplaces to foster the inclusion, health, and development of some of their most vulnerable members.